Cytoskeletal Control of Yap in Heart Regeneration

Project Summary / Abstract
The Hippo-signaling pathway (HSP), a kinase cascade, inhibits nuclear localization and transcriptional
activity of YAP, a transcription co-factor. In previous work, deletion of the HSP component Sav in mouse and pig
cardiomyocytes (CMs) with established ischemic cardiomyopathy and heart failure (HF), results in reversal of
HF and improved heart function due to increased nuclear YAP and activation of YAP target genes. These
groundbreaking findings indicate that uncovering methods to modulate YAP activity is valuable to treat ischemic
cardiomyopathy and HF, which is the goal of this research program. Importantly, YAP is primarily regulated by
post-translational modifications (PTMs), which control YAP nuclear/cytoplasmic subcellular localization
dynamics. HSP kinases inhibit YAP nuclear localization by phosphorylating conserved serine residues in YAP.
When HSP activity is low, YAP enters the nucleus and complexes with Tead family transcription factors to
activate genes involved in progression through multiple cell cycle phases. In addition to HSP-mediated
phosphorylation, the recent discovery that a Lysine acetylation-deacetylation cycle controls YAP nuclear-
cytoplasmic localization provides an opportunity to develop novel therapies for cardiomyopathy, which will be
investigated in this research program.
Protein acetylation-deacetylation is very sensitive to the metabolic state of the local cellular environment.
During myocardial infarction (MI), metabolism quickly shifts from mitochondrial oxidative phosphorylation to
glycolysis due to oxygen deficiency in CMs. Consequently, Lysine acetylation, one of the main PTMs closely
associated with metabolism, is also altered. The notion that HF-altered myocardial metabolism contributes to
disease pathogenesis and that regulating it may serve innovative therapeutic purposes underscores the
importance of identifying the metabolic characteristics of HF patients. It is therefore critical to clarify how YAP
responds to post-MI environmental factors or metabolic changes. The proposed studies are based on preliminary
data revealing that following MI, YAP acetylation is required for YAP/cytoskeleton interactions, wherein YAP
binds the non-muscle actin filaments. These data reveal an MI-induced metabolic shift pathway wherein
acetylation promotes YAP sequestration with the stabilized microtubule network in the cytoplasm, which is
detrimental to cardiac regeneration. The aims of these proposed studies are to investigate phosphorylated and
acetylated YAP in the contexts of HF and low HSP activity using advanced genomics, gene therapies, and
mouse HF models. These studies will reveal how metabolic shifts after MI regulate YAP activity via Lysine
acetylation in CMs and how YAP regulates the CM cytoskeleton. Using clinically approved compounds that
target metabolic substrates/intermediates, Lysine acetyltransferases, and Lysine deacetylases, these
studies will guide the development of new strategies to target YAP acetylation for HF treatment.

Public health relevance
Project Narrative The Hippo-signaling pathway (HSP), a kinase cascade, inhibits nuclear localization and transcriptional activity of YAP, a transcription co-factor via post-translational modifications. Disruption of the HSP 1) reverses established ischemic cardiomyopathy and heart failure and 2) improves heart function in mouse and pig cardiomyocytes due to increased nuclear YAP and activation of YAP target genes. We will explore the mechanism(s) through which YAP Lysine acetylation and phosphorylation regulates heart regeneration, and how these mechanisms can be leveraged in HF therapies.